Task Order No.61 - 5th International Conference on Ambulatory Monitoring of Physical Activity and Movement (ICAMPAM 2017) - Meeting Support

5th International Conference on Ambulatory Monitoring of Physical Activity and Movement (ICAMPAM 2017) - Meeting Support